2016 Enzymes, Coenzymes and Metabolic Pathways Gordon Research Conference & Gordon Research Seminar

Project Summary With this proposal we seek partial support for the 2016 Enzymes, Coenzymes, and Metabolic Pathways GRC/GRS. These conferences will occur July 23–24 (GRS) and July 24-29 GRC, 2016 at the Waterville Valley, in Waterville Valley, NH. The “Enzymes” GRC/GRS is the pivotal conference for researchers focused on investigating the molecular mechanisms of biochemical reactions and provides a central meeting place for the exchange of ideas. The long-term goals of this conference are to foster interactions and communication within the research community focused on studying the roles of enzymes in the biological processes that are fundamental for life. To achieve these goals, the GRC has created a program of ~36 Speakers (28 invited and 8 chosen from poster abstracts), and the GRS has put together a program of ~9 Speakers (1 invited and 8 chosen from poster abstracts) as well as a Bioscience Careers Panel (5 leaders from diverse backgrounds). These talks will describe current advances in enzyme mechanisms, antibiotic biosynthesis, and antibiotic resistance, as well as how these areas link to disease processes. During the afternoon, poster sessions will be held where all attendees can present their work to the broader community of scientists. These poster sessions provide a unique opportunity for junior scientists and senior investigators to interact. This proposal is highly significant because the Enzymes, Coenzymes, and Metabolic Pathways GRC/GRS is the pivotal conference for researchers focused on investigating the molecular mechanisms of biochemical reactions and provides a central meeting place for the exchange of ideas. Furthermore, this meeting continues to showcase the very best in enzyme and metabolic studies as well as their relevance to human diseases. From a medical perspective, this proposal is highly significant due to the focus areas of antibacterials and the development of new pharmaceuticals. A key outcome of this proposal will be to further advance our understanding of how enzymes, co-enzymes and metabolic pathways can contribute to the development of new antibiotics.

Public health relevance
Project Narrative Enzymes and coenzymes enable the primary and secondary metabolism of all organisms and play key roles in healthy and disease states. A major challenge for the enzymologist is to utilize knowledge of these transformations and pathways in order to treat or cure disease. How these processes occur and what can be done to manipulate them to improve human health are central topics discussed at our meeting.